Training

Abstract: Training. Highly advanced methods of data collection and computational analysis for biological NMR continue to make great strides, but their adoption by the broader bio-NMR community remains frustratingly low, in part because they require substantial technical support and training. The proposed Center decreases the barriers to adopting advanced methods by providing a single access point to a rich collection of documentation and training materials that address the needs of both spectroscopists and software developers. The primary access point for the training resources is the Center Web Portal. The portal connects users to resources that are delivered in multiple mediums through the following outlets: (1) NMRbox Reference Guides ? A collection of installation and configuration guides for NMRbox will be produced for VMware and VirtualBox hypervisors running on the OSX, Windows and Linux operating systems. (2) Software Catalog ? Each software package contained in NMRbox is listed in the catalog with a brief description of the software package to facilitate discovery, PubMed links to the associated primary references in the literature to encourage proper citation, links to reference materials hosted on the developer's website for easy access, and links to any training materials developed by the Center that involve the software package. (3) “Virtual Office Hours” ? The Center staff and developers will make themselves available to screen-share an NMRbox session with users to provide real-time support. (4) Workshops ? An annual workshop with user and developer sessions will be run to provide the community with intensive, hands-on training. Single day workshops will be scheduled in conjunction with various national conferences to ensure that NMRbox is made available to the broad community. (5) Forums ? Online discussion forums will give users and developers a community-driven opportunity to discuss all aspects of NMRbox usage. These forums will also inform the Center staff about consensus topics that require additional training materials. (6) YouTube Channel ? An NMRbox channel will be created to host a consolidated collection of video tutorials produced by Center staff and developers. Workshop presentations and virtual office hour sessions will also be included. (7) Script Repository ? Users and developers will likely write their own small utility scripts to accomplish specific tasks in their processing workflow. For users willing to share these scripts, the Center will harvest them from the forums and host them on the Center portal and provide direct access from within NMRbox. This resource will help users and serve to inform the developer community about tasks that require robust solutions.